Identification of Sex Differences in Monocytes and Metabolism in the Maintenance of Chronic Muscle Pain

Project Summary
Fibromyalgia is a chronic musculoskeletal pain disorder that has a strong negative impact on quality of life and
is strongly biased towards women. There is a dire need for the development of targeted therapeutics as patients
are not responsive to current therapeutics. The significantly greater prevalence of chronic muscle pain in women
suggests female-biased mechanisms in the pathophysiology of its development and maintenance. Recent
literature on neuroimmune communication in chronic pain signaling have uncovered sexually divergent
mechanisms; however, there are little to no studies assessing how cellular metabolism in immune cells can
modulate pain processing. The research plan during the F99 phase of this proposal will test the specific
hypothesis that maintenance of chronic muscle pain is mediated by sex-specific differences in monocyte
activation and metabolism using a mouse model in which metabolism of monocytes is modulated by deletion of
liver kinase B1 (LKB1), a metabolic kinase. Anti-inflammatory functions are much more metabolically demanding
than pro-inflammatory functions, so these cells will have diminished anti-inflammatory activation. We anticipate
monocytes without LKB1 have a magnified pro-inflammatory phenotype during chronic muscle pain that is
maintained by distinct translational profiles in males and females. Assessment of pain behaviors, RNA
sequencing, flow cytometry, and cellular metabolism assays will allow for the identification of phenotypic changes
within peripheral monocytes driving the development and maintenance of chronic muscle pain. The work and
described in the F99 phase of this proposal will further our understanding of sexually dimorphic mechanisms of
immunometabolism as a driver of chronic muscle pain and provide direction for the development of targeted
therapeutics to reduce the impact of chronic muscle pain on patient quality of life. The focus of the K00 phase
will be to study immunometabolism and chronic pain in patients with fibromyalgia using neuroimaging and
expanding skillsets in immunology and computational biology. The ultimate goal of this proposal is preparation
for transition to a faculty position in neuroscience at a research institution as an independent translational
neuroimmunologist with a special focus on identification of sex-biased mechanisms in chronic muscle pain.

Public health relevance
Project Narrative Recent key studies have demonstrated that immune dysregulation is a defining component of fibromyalgia and chronic muscle pain. The goal of this proposal is to assess the mechanisms by which immunometabolism differentially contributes to chronic muscle pain in male and female mice. Understanding the metabolic processes underlying female-biased mechanisms will bolster research efforts in the development of novel targeted therapeutics for the alleviation of muscle pain.